Administrative Core

Administrative Core- Project Summary
The Administrative Core provides the overarching leadership that sets the tone, philosophy, and
scientific vision of the University of Washington Alzheimer’s Disease Research Center (UW
ADRC) for the next 5 years and beyond. It ensures that the UW ADRC supports the needs of UW, regional,
and national Alzheimer’s disease and related dementias (ADRD) investigators and their projects. It does so by
providing expertise and well-developed research resources. We enable clinical research which might not
otherwise be possible to accomplish due to the time, expense, and expertise it takes to obtain well-
characterized and deeply phenotyped human participants and the biospecimens obtained from them. The Core
administers a vibrant developmental research project program, focused on young investigators, and closely
linked to the Research Education Component. The Administrative Core situates and advocates for the ADRC
in its overall institutional setting, working closely with UW Medicine Advancement and UW School of Medicine
leadership to articulate, support, and sustain the initiatives that optimize our impact within the institution, in the
national Alzheimer’s Disease Centers Program, and across the broader community of investigators devoted to
developing solutions for ADRD. The Core ensures that the data and biospecimens created in the course of this
research are available to these communities. It also works proactively to ensure that diverse perspectives are
included in the leadership and staff, and inform the development of all the resources of the Center. The Core
also fosters a timely and visionary collaboration with the Institute for Research and Education to Advance
Community Health to build research resources for investigating ADRD in American Indians and Alaska
natives.